The Computational Tumor Immunology Core (CTIC)

CTIC Core: Project Summary/Abstract
The Computational Tumor Immunology Core (CTIC) will provide CAP-IT CRI researchers with state-of-the-art
computational genomic, tumor immunology, immunopeptidomic, and spatial genomic services to support
research projects for immunoprevention of patients with a. Lynch syndrome (LS; Project 1), b. lung cancer non-
solid nodule (NSN), pre-malignant neoplasms (Project 2), and c. any new CAP-IT projects that are subsequently
approved by the CAP-IT program. CTIC investigators include accomplished leaders in computational cancer
genetics, tumor immunology, single-cell profiling, and spatial genomics. We have significant experience with all
proposed analyses to be performed. As the CTIC areas of focus are dynamic and rapidly evolving, we anticipate
incorporating new technologies and computational strategies as they develop to help drive Projects 1 and 2. The
CTIC will successfully delineate LNP RNA immunoprevention and immune interception vaccines for LS and NSN
patients and provide necessary shared resources for the CAP-IT, network-wide.